Increasing the Value of Genomic Medicine through Private Pharmacogenomic Reporting

Abstract
Genomic sequencing promises to transform medicine, yet the current economics of genetic and
genomic testing prohibit widespread adoption. Of particular interest is pharmacogenomics
(PGx), with the potential to transform precision medicine through understanding
gene-drug-disease associations, mapping of drug pathways, identification of drug targets, and
minimization of drug toxicities. Despite its potential, PGx has yet to be widely implemented in
clinical care and is hindered by high costs of genomic sequencing, lack of standardized and
interoperable data, and lack of clinician education in interpreting complex genomic reports.
We aim to solve these problems through the development of a HIPAA-compliant,
privacy-preserving PGx platform in which patients can maintain ownership and
transactional-level control of data use, thereby protecting patient privacy while facilitating use
and reuse of genomic data. This tool will include streamlined report generation, an encrypted
database supporting encrypted queries against PGx data, and access via API or user-friendly
web and mobile applications.
Our innovative encryption technology offers an unprecedented level of privacy, never exposing
unencrypted sensitive data to third parties (e.g. data storage or compute providers) or other
intermediaries. Additionally, by only delivering the standardized data needed for a given
context, interoperability and integration with existing clinical workflows (e.g. EHR or clinical
decision support platforms) is streamlined and the burden of clinicians to independently analyze
lengthy or complex reports is reduced. Ultimately, this project aims to increase the value of
genomic sequencing and the availability of standardized PGx data at the point of care.

Public health relevance
Narrative Pharmacogenomic (PGx) data can provide valuable, personalized insights in optimizing treatment for any disease or condition, but its integration into healthcare systems is barred by high costs, lack of access due to privacy issues, and difficulty interpreting data. We aim to build a privacy-preserving PGx platform in which data owners maintain ownership and transactional-level control of data use, thereby protecting patient privacy while facilitating use and reuse of genomic data. This tool will increase the value of genomic sequencing and the availability of standardized PGx data at the point of care.